Organization of transcriptional machinery by weak multivalent interactions

Project Summary
Weak multivalent interactions mediated by intrinsically disordered regions (IDRs) of proteins have been proposed
to spatially organize the transcriptional machinery into multi-component clusters, yet we know little about how
these IDRs interact with specific partners to enable functional outcomes. As these interactions are highly
dynamic and cluster-dependent they have been overlooked by conventional strategies to identify protein-protein
interactions. Our preliminary data support our overarching hypothesis that in the context of higher-order clusters
weak multivalent interactions are capable of highly specific hetero-typic interactions leading to functional
organization of the nucleus. Our long-term objective is to understand how weak multivalent interactions organize
specific components of the transcriptional machinery in order to enable gene activation. The objective of the
parent grant is to investigate the mechanism and function of cluster-mediated interactions of IDR of found on
transcriptional coactivators. The proposed work in the diversity supplement focusses on investigating myocardin
(MYOCD), a smooth muscle cell specific coactivator. The proposed work is directly related to Aim 3 of the parent
grant, which proposes to investigate the functional role of coactivator IDRs in various models of gene activation
including reporter assays and cell models of cellular differentiation. MYOCD is a smooth muscle cell specific
coactivator, and we will be investigating the role of its IDR in reporter assays and smooth muscle cell
differentiation. Completion of these studies will advance the goals and objectives of the parent grant and will
teach us about how the function of prevalent yet often overlooked IDRs in gene activation.

Public health relevance
Project Narrative Turning on the right gene at the right time is essential for development and requires the dynamic recruitment of dozens of regulatory factors to specific genomic loci; defects in this process cause human disease. Emerging evidence supports a role for weak multivalent interactions in organizing regulatory factors into multi-component clusters that assemble and disassemble dynamically, yet these types of interactions have been difficult to study as they are only stabilized under specific conditions which enable cluster formation. Investigation into the mechanisms and functions of these weak multivalent interactions in the context of cluster formation will provide novel insights into a fundamental biological process with implications for developmental processes and aberrant gene activation in disease.